Path C Ohio's Plan to Implement a National Produce Safety Program

Ohio-Project Summary
The Ohio Department of Agriculture will continue to development and implement a produce safety
program based on the FDA’s Produce Safety rule. This will help advance efforts for a national integrated
food safety system. To that end, Ohio will be following Path C. We will be conducting inspections under
our own authority, providing educational opportunities and outreach such as on farm consultations; and
continue to determine Ohio’s produce grower inventory. Ohio falls into band 4 for education and
inventory and band 5 for regulatory activities. Ohio will share all information concerning our produce
safety program, with the FDA.
Ohio’s jurisdictional authority can be found in https://codes.ohio.gov/ohio-revised-code/chapter-925 ,
Ohio Revised Code 925.54. Ohio has adopted the Produce Safety rule by reference and can be found at
https://codes.ohio.gov/ohio-administrative-code/chapter-901:3-12 , Ohio Administrative Code 901:3-
12.

Public health relevance
Ohio- Project Narrative The Ohio Department of Agriculture’s development and implementation of a produce safety program is a part of a national effort to advance a national integrated food safety system (IFSS). Funding of this application help promote an IFSS and it will allow Ohio to share program information such as inventory, with the FDA.